Biostatistics and Bioinformatics core

Project Summary.
The Biostatistics & Bioinformatics Resource Core (BBC) supports vision scientists at Washington University by
providing assistance with experimental design and analysis of quantitative data. In response to the expressed
needs of the user group, the core has been strengthened significantly by incorporation of enhanced
Bioinformatics support. Thus, in addition to offering the full range of conventional tools for statistical analysis of
biomedical data, the core now provides help with interpretation, management, and analysis of very large data
sets (such as those generated through NGS deep sequencing of somatic variants, proteomics, single cell RNA
sequencing, and ChipSeq). We anticipate that the integration of computational biology into our established
Biostatistics Core, will result in the BBC exceeding the expectations of our user group, allowing investigators to
explore powerful technologies that might previously have fallen outside their area of expertise.